The Open EEGLAB Portal Project

Electroencephalography (EEG), the first function brain activity imaging modality, has several natural advantages over metabolic brain imaging modalities. EEG is noninvasive, low cost, and lightweight enough to be highly mobile. Two major shifts in scientific perspective on the nature and use of human electrophysiological data are now ongoing. The first is a shift to using EEG data as a source-resolved, relatively high-resolution cortical source imaging modality. The second is a shift from recording electrophysiological data with at best a scant record of behavior (e.g., latencies of occasional button presses) to concurrently collecting and combining EEG data with other data modalities (e.g., body motion capture, eye tracking, audio and video, ECG, EMG, GSR, MEG, fMRI, etc.), paradigms that we term Mobile Brain/Body Imaging (MoBI) to capture brain activities and subject actions during natural, motivated behavior.The EEGLAB signal processing environment, an open source software project of the Swartz Center for Computational Neuroscience (SCCN) of the University of California, San Diego (UCSD), began as a set of EEG data analysis running on Matlab (The Mathworks, Inc.) released by Makeig on the World Wide Web in 1997. EEGLAB was first released from SCCN in 2001. Now nearly twenty years later, the EEGLAB reference paper (Delorme & Makeig, 2004) has over 4,100 citations (now increasing by over 3 per day), the opt-in EEGLAB discussion email list links over 5,500 researchers, the EEGLAB news list over 15,400 researchers, and a survey of 687 research respondents reported EEGLAB to be the software environment most widely used for electrophysiological data analysis in cognitive neuroscience. Currently, at least 52 EEGLAB plug-in tool sets have been released by other researchers from many laboratories. Here we propose, first, to greatly augment the power of the EEGLAB environment by enabling it to perform time series, biophysical, and statistical analyses of multimodal as well as unimodal EEG data. However, ever more precise analyses of large and multimodal data sets and studies require increasing amounts of computational power, more than is readily available in many laboratories. Thus second, in collaboration with the San Diego Supercomputer Center (SDSC) we propose to expand the current Neuroscience Gatew? ay (?nsgportal.org) services to enable EEGLAB users to freely run EEGLAB processing scripts and pipelines on SDSC supercomputers. The proposed Open EEGLAB Portal will allow researchers to submit any amount of unimodal or multimodal EEG data for parallel processing using standard or custom EEGLAB processing pipelines. We will also develop and release first tools for meta-analysis of source-resolved EEG measures ?across studies. Multimodal EEG analysis and source-level EEG analysis accelerated by free use of supercomputing resources will give the EEG research community unprecedented abilities to observe and model distributed cortical dynamics supporting human experience and behavior.

Public health relevance
A major shift in scientific perspective on the nature and use of human electroencephalographic (EEG) data is now ongoing -- from recording only a scant record of concurrent subject behavior (e.g., button press latencies) to collecting multimodal brain and behavioral data concurrently (EEG plus body motion capture, eye tracking, fMRI, MEG, ECG, EMG, MEG, etc.), and replacing scalp EEG channel measures with source-resolved and source-localized measures of cortical EEG dynamics. The EEGLAB signal processing environment, an open source software project of the Swartz Center for Computational Neuroscience (SCCN), is now used in a large number of EEG and related electrophysiological research and teaching laboratories worldwide. To accelerate progress in basic and clinical cognitive neuroscience, we propose, first, to augment the EEGLAB software environment to enable it to support complex and EEG source-resolved analyses of multimodal EEG data sets and studies and second, to provide the EEG research community using EEGLAB free, ready access to national supercomputing resources by opening an Open EEGLAB Portal within the Neuroscience Gateway (n sgportal.org).